Maternal microbial exposure fundamentally shapes the CD8 T cell population at the maternal fetal interface

ABSTRACT
CD8 T cells are potent killers of cells presenting foreign antigens, making them powerful to fight microbial
infections. The fetal host immune defense against pathogenic microbes is underdeveloped and ill-equipped to
defend against microbial infection and heavily relies on maternal host immune responses to prevent the
dissemination of pathogenic microbes. However, the fetus also expresses immunologically foreign allo-
antigens, which if recognized by CD8 T cells, could threaten its survival. The maternal-fetal interface (MFI),
where fetal and maternal mucosal tissues intertwine, is a critical location for preventing the dissemination of
pathogenic microbes and maintaining tolerance for allo-antigens. Major gaps in knowledge relating to CD8 T
cell biology, tolerance, and pathology at the MFI have persisted due in large part to necessary restriction on
using human cells and tissues for research. In addition, conventional specific pathogen free (SPF) mouse
models fail to recapitulate human CD8 T cell biology and diversity, both systemically and in tissues, making
them inadequate for studies on CD8 T cells at the MFI. In SPF mice, CD8 T cells make up 0.5-2% of MFI
leukocytes and have a naïve phenotype. Conversely, we recently discovered that natural microbial exposure
expanded CD8 T cells to 6% of leukocytes at the MFI and phenocopied human CD8 T cells with high fidelity.
This proposal uses innovative natural microbial exposure as a more faithful model system of human CD8 T cell
biology. Natural microbial exposure expanded CD8 T cell numbers and generated additional CD8 T cell
diversity including effector, memory, tissue resident and dysfunctional CD8 T cell types that we also observed
at the human MFI. We utilize this model as well as human tissues to gain mechanistic understanding of factors
that modulate CD8 T cell tolerance and host immune defense against pathogenic microbes at the MFI. We will
compare the immune regulation of CD8 T cells are a result of exposure to a natural microbiome or pathogens
both systemically in blood and lymphoid tissues as well as locally in the mucosal tissues. These mechanistic
investigations of adaptive CD8 T cell responses will identify tissue localized CD8 T cell types, their receptors
and specificity, as well as the beneficial and pathogenic host factors providing immune protection for
pathogenic microbes while maintaining immune tolerance. Further, these experiments will lay the groundwork
for improved preclinical models investigating biomarkers, treatments, and preventions for immune pathologies
at the MFI.

Public health relevance
PROJECT NARRATIVE The key function of CD8 T cells is to eliminate pathogens, based on recognition of foreign antigens. However, during gestation CD8 T cells must be tolerized to prevent rejection of the concepti. The experiments described in this proposal are designed to gain mechanistic understanding of how the conflicting demands of CD8 T cell tissue tolerance and host defense are balanced at the maternal fetal interface (MFI).